Vagus nerve modulation of hippocampus function.

Project Summary / Abstract
The vagus nerve is the main conduit of information between the gastrointestinal (GI) tract and the
central nervous system. In addition to communicating meal-related satiation signals from the GI tract to the
brain to control meal size1, vagal afferent neurons (VAN) also relay information from the gut to the brain to
promote the function of the hippocampus (HPC) – an integral brain structure in the regulation of learning and
memory. Emerging evidence indicates that the vagus nerve plays a role in the regulation of cognitive processes
such as motivation, anxiety, and memory2. Work from our group has revealed that selective ablation of GI-
originating vagal afferents impairs HPC-dependent memory function in rodents3,4. The neurobiological
mechanisms by which VAN promote memory function, however, remain unclear.
Recently, the primary mentor’s group identified the medial septum (MS) as a region relaying signals between
the VAN and the dorsal subregion of the HPC (HPCd)3. The MS extensively innervates the HPCd with
acetylcholine (ACh)-producing fibers and is integral in the regulation of HPC-dependent memory function5.
Thus, we hypothesize that physiological signals that originate from the gut that engage the VAN to modulate
HPCd function via MS ACh signaling. Further, reductions in MS-to-HPCd ACh signaling are considered a
pathological hallmark of Alzheimer’s disease (AD)6. AD currently affects ~24 million individuals and is marked
by reduced ACh tone in the HPCd6. We hypothesize that potentiation of the VAN-HPCd cholinergic pathway
through vagus nerve stimulation (VNS) may yield neuroprotective effects against AD and related dementias.
Given the uncovered role of the vagus nerve in the regulation of learning and memory, understanding
the neural substrates for how the vagus nerve regulates memory in the HPCd is critical for the development of
novel therapeutics to treat and/or prevent AD. Preliminary results from fiber photometry recordings indicate
that HPCd ACh is released during food consumption, with robust elevations in HPCd ACh release levels upon
satiation. Aim 1 experiments build off these findings by examining HPCd ACh responses during intragastric
infusion of different macronutrients, peripheral delivery of known satiation signals, and during the intake of
isolated macronutrients to unravel what drives meal-induced HPCd ACh release. Moreover, given that various
VAN loss-of-function models (e.g., sub-diaphragmic vagotomy), which have been established to cause HPC
dysfunction, yield dysregulation of HPCd ACh signaling, we posit that vagus nerve signaling promotes HPC
function. Given that VNS paired to ingestive events is sufficient to rescue diet-induced HPC memory deficits,
Aim 2 experiments will use a transgenic rodent model of AD (TgF344-AD)7,8 to assess meal-associated HPCd
ACh responses using fiber photometry and explore the therapeutic potential of our novel VNS approach for
improving AD-associated cognitive impairments. Overall, the outcomes of the proposed research will improve
our understanding of the role of VAN in physiological HPC memory maintenance and AD etiology.

Public health relevance
Project Narrative Alzheimer’s Disease is a condition currently estimated to affect 24 million individuals, projected to double in prevalence every 20 years, that is characterized by impaired signaling of the neurotransmitter acetylcholine in the hippocampus. Recent research has identified a role for the vagus nerve in relaying signals from the gastrointestinal tract to the hippocampus that underlie cognitive processes such as learning and memory. Here, we investigate how gut-derived vagus nerve signaling modulates hippocampal function via acetylcholine transmission, and how this gut-to-hippocampus pathway may be harnessed as a therapeutic outlet for cognitive dysfunction with the end goal of providing basic science insight into the treatment, and ultimately prevention, of Alzheimer’s Disease.